WILL TESTOSTERONE IN HYPOGONADAL MEN INCREASE BONE MINERAL DENSITY?

The is a multi-center study to determine if increasing the serum testosterone concentrations of hypogonadal men to normal will increase their muscle strength and bone mineral density to normal. We are attempting to recruit 35 men and increase their serum testosterone concentrations to normal using a testosterone impregnated membrane.